Identifying Molecular Signatures of Genomic Imprinting Errors

Abstract
Alarmingly, ~50 million couples worldwide are unable to conceive after 5 years of unprotected sex. Medically
assisted reproductive technologies (ARTs) constitute important treatment modalities for infertile couples trying
to conceive. While generally considered safe, ARTs are associated with higher incidences of preterm birth,
intrauterine growth restriction, and low birth weight. Moreover, there are more Beckwith-Wiedemann, Silver-
Russell, Angelman and Prader-Willi Syndrome children in the ART population harboring imprinted methylation
errors compared to those in the general population. Since ART usage coincides with important stages of
imprinted DNA methylation programming during gamete and preimplantation development, it is possible that
ARTs lead to imprinting errors. Studies in fertile mice support this. Superovulation during oogenesis and/or
embryo culture during preimplantation, two nearly universal ART procedures, lead to significant numbers of
embryos with imprinted methylation errors. To date, little is known about the regulation of imprinted methylation
maintenance during preimplantation development, and moreover, how ARTs lead to disruption in this
maintenance. This proposal will address these knowledge gaps. In Aim 1, we will test the hypothesize that
embryos are predisposed to imprinted methylation errors because ARTs disrupt crucial maternal-effect
transcripts in oocytes that are required in embryos to maintain imprinted methylation. Candidate maternal-
effect transcripts will be identified using single cell RNA-seq on control and superovulated oocyte, 1-cell and 2-
cell embryos, representing the period of oocyte-to-embryo transition. Candidate function will then be
determined though protein degradation methods. Next, we will determine whether altered maternal-effect
transcripts in polar bodies, as a proxy for oocytes, correlates with imprinted methylation errors in resulting
embryos, ultimately leading to identification of transcript biomarkers that are predictive of imprinted methylation
errors. Aim 2 will test the importance of nuclear import in imprint maintenance using pharmacological and
protein degradation methods, and whether it is disrupted by ARTs. In Aim 3, we hypothesize that the 4 to 8-cell
stages represent a window of susceptibility when fast developing ART embryos acquire DNA methylation
errors, particularly in outer, trophoblast cells. We will determine when embryo development is altered by ARTs
using time-lapse analysis, and then compare DNA methylation perturbation in slow and fast developing
embryos using whole genome bisulfite mutagenesis. This will distill a molecular signature of DNA methylation
errors. Next, we will investigate this molecular signature during early development to determine when DNA
methylation errors arise and in which lineages of ART embryos, as well as in cells induced to trophoblast fate.
Finally, we will test the predictive power of developmental and morphokinetic parameters as a noninvasive
procedure for embryos with a molecular signature of imprinted methylation errors. Results from this proposal
will provide the biological basis for improvements to fertility treatments aimed at identifying at-risk embryos.

Public health relevance
Narrative Genes within humans and other mammals are marked with chemical tags that direct normal embryonic development. Assisted reproduction technologies that help infertile couples conceive may disrupted these chemical tags in resulting embryos. This research proposal will identify chemical signatures that discriminate embryos with and without errors and noninvasive approaches to distinguish between these embryos.